Isovolumetric Multimodal Venous Thrombectomy System

ABSTRACT
This Phase II STTR application from Caeli Vascular, LLC entails a 24-month period focused on further
development of a novel multi-modal venous thrombectomy device. The PI is a vascular surgeon with
biomedical research and entrepreneurship experience, and is supported by a team of highly qualified
investigators, including a vascular biologist, neurosurgeon, veterinarian, biomedical engineer, mechanical
engineer, and a team of marketing and management experts. The primary objective of this application is to
build on successful Phase I feasibility studies, and further develop the Hydra Catheter Thrombectomy System
technology to address all current gaps in the state of the art for the treatment of large-volume deep venous
thrombus (DVT).
Each year, more than 900,000 Americans will develop a large-volume DVT, and up to 100,000 of these will
die as a result of a complication within 2 weeks of diagnosis. Treatment options of large-volume DVT are
limited, and currently available percutaneous endovascular thrombectomy devices have various shortcomings
that impact treatment efficacy and safety. Major gaps include increased risk of intra-procedural thrombus
embolization leading to a pulmonary embolus (PE), systemic leak of chemical thrombolytic medication leading
to increased risk of bleeding, risk of vein wall and valve trauma leading to chronic impairments, and inability to
completely remove thrombus leading to unresolved DVT. To address all the gaps in the state of the art of
percutaneous venous thrombectomy devices we designed and prototyped the Hydra Catheter Thrombectomy
System. Unique and proprietary features of the device include adjustable ecapsulation balloons, an infusion
catheter segment to facilitate localized and judicious delivery of chemical thrombolytics, a rail-mounted leaflet
agitator that does not engage the vein wall, and mechanism for isovolumetric suction and infusion to facilitate
flushing of thrombus fragments and thrombolytics from the venous treatment zone. Phase I studies
demonstrated the feasibility of the device to prevent distal microembolization, prevent vein wall collapse and
over-distension, and achieve effective removal of luminal thrombus in an ex vivo flow system. In this Phase II
study, our team will further develop key component of the device and evaluate the efficiency of the technology
ex vivo and in vivo with the following specific aims:
Aim 1: Develop and test a newer generation Hydra Pump to facilitate isovolumetric suction and infusion
through the Hydra Catheter Thrombectomy System in an ex vivo flow system.
Aim 2: Evaluate Hydra Catheter Thrombectomy System efficacy and preliminary safety in a validated in
vivo porcine vena cava DVT model
By completing these proposed aims we will be able to achieve the design specifications and Good
Laboratory Practice (GLP) animal studies that are required for FDA 510(k) device application submission.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH STATEMENT Over the last two decades deep venous thrombosis (DVT) has become a national and international health concern that impacts at least 700 per 100,000 individuals, and leads to 60,000-100,000 deaths per year. Currently there are significant limitations with existing devices for the treatment of large-volume DVTs. Caeli Vascular developed the Hydra Catheter Thrombectomy System, which is a novel device that synergies the use of adjustable balloon encapsulation, clot flushing, and chemical and mechanical clot fragmentation techniques. Our device will offer patients an efficient, safer, and more cost effective method for treatment of DVT – and has the potential of saving many lives.